STRUCTURE AND FUNCTION OF CD2AP IN THE KIDNEY

Project Summary/Abstract This is the second renewal application for this project to understand the role of genetic changes in the pathogenesis of glomerular diseases like focal segmental glomerulosclerosis (FSGS). In this application, we propose two specific aims. In the first, we propose to characterize a gene that we discovered that is highly expressed in podocytes. This gene, ARHGAP24, is a known regulator of the actin cytoskeleton and the high expression of this gene implicates a specific actin regulatory pathway in the normal function of podocytes. To test the role of this gene in the glomerulus, we propose to generate and characterize a mouse that lacks expression of ARHGAP24. In the second aim, we will set-up a genetic screen that combines RNAi technology and state of the art mouse genetic methods to perform a genetic screen in mouse to identify genes that when mutated contribute with CD2AP and another podocyte specific gene, synaptopodin, in the pathogenesis of glomerular dysfunction. Our long-term goal is the identification of all genes that, when mutated, contribute to the pathogenesis of human FSGS.

Public health relevance
PROJECT NARRATIVE The goals of this project are to better understand the genetic causes of kidney disease. We will test the role of specific genes in the development of kidney diseases. __SpecificAimsTextDelimiter__ Specific Aims: Chronic kidney diseases, of which glomerular diseases form the most significant component, are extremely common and estimated to effect from 5-11% of the adult population. Treatment options are extremely limited and this is largely due to the poor understanding of their pathogenesis. While environmental factors play a key role in the pathogenesis of disease, important breakthroughs in the field support an important role for genetic factors. The important role of genetics is supported by the almost four-fold increased incidence in African- Americans [1, 2] and the strong predictive power of family history in the susceptibility to glomerular diseases like focal segmental glomerulosclerosis [3]. Our work with CD2AP in the podocyte played an important role focusing attention on the podocyte as a key component of the filtration barrier and supported the idea that podocyte dysfunction is an important component of glomerular disease. This grant, now in its 10th year, has supported most of our work on CD2AP. In the first funding period and resulted in over 20 publications. In the first funding period, we determined: 1) the expression pattern of CD2AP in mouse 2) the renal phenotypes of mice lacking CD2AP or exhibiting haploinsufficiency, and 3) began our studies to understand the function of CD2AP in podocytes. In the second funding period, we proposed that the podocyte plays a central role in the clearance of serum proteins that enter the glomerular basement membrane. We therefore proposed to: 1) study the role of combined heterozygosity in susceptibility to glomerular dysfunction 2) determine the role of an IgG and albumin receptor, the neonatal Fc receptor (FcRN) in the podocyte 3) study the role of macropinocytosis in the podocyte. Our work in the last few years has increasingly focused on the identification of podocyte susceptibility genes that will be important in human disease. In this first resubmission proposal, we propose to further investigate a new potential podocyte susceptibility gene, ARHGA24, that we discovered by searching for podocyte specific genes. In the second aim, we propose a novel method of performing genetic epistasis studies in the mouse, with the ultimate aim of identifying many more podocyte susceptibility genes. 1. Determine the role of ARHGAP24 in podocytes. We identified a novel gene ARHGAP24 (Ohta et al., 2006) as podocyte specific by careful analysis of expression profile data that we generated from podocytes. To investigate its role in human disease, we sequenced several hundred FSGS patients and identified a variety of missense mutations that could be involved in some cases of FSGS. Here we propose to study the function of ARHGAP24 in podocytes and to generate an ARHGAP24 knock-out mouse to determine how the gene contributes to podocyte function. 2. Identify genes that are epistatic with CD2AP in the podocyte. This aim is based on two of our findings. 1. CD2AP mutations are present in some patients with FSGS. 2. Heterozygosity of CD2AP combined with heterozygosity of Fyn or synaptopodin strongly enhances susceptibility to proteinuria in mouse. This supports the idea that the pathogenesis of FSGS will involve subtle mutations of multiple genes, each contributing only a small risk. Based on our preliminary data suggesting that CD2AP and myosin IIa (myh9) genetically interact, in the first part of this aim, we propose to test whether combined heterozygosity of CD2AP with the myh9 gene will enhance the development of podocyte dysfunction. We will also test combined heterozygosity of myh9 with Fyn and synaptopodin. In the second part of this aim, we will use a new genetic approach that will allow the use of shRNA to identify genes that are epistatic with CD2AP and myh9. We will generate sensitized mouse ES cells that are heterozygous for CD2AP, synaptopodin and myh9 and/or combinations of these three genes. We will target shRNA constructs to the hgprt locus. We will begin by testing genes that are known to be involved in causing podocyte dysfunction, like CD2AP, a-actinin-4 and podocin to validate our system. We will then test shRNAs for 24 genes that we suspect to genetically interact with CD2AP. The application of next generation sequencing technologies to FSGS patient is likely to result in the identification of hundreds to thousands of DNA variants of unknown clinical significance. The challenge that faces medical research is to develop no methods that will allow us to identify which combinations of genetic mutations are involved in the susceptibility to FSGS. We believe that methods, like the one we proposd here, will prove invaluable in the challenge to prove which human DNA variants are involved in disease susceptibility.